Clinical Core

Project Summary/Abstract - Clinical Core
The Clinical Core of the Michigan Diabetes Research Center (MDRC) provides resources and expertise to
enhance the effectiveness, efficiency, and multidisciplinary nature of clinical research performed by MDRC
investigators. Specifically, the Clinical Core provides resources and expertise to support clinical research that
focuses on moving basic science discovery and preclinical development into people with diabetes in order to
enhance human health and well-being. This bench-to-bedside process may involve testing new drugs, devices,
or treatment programs for patients at risk for or with diabetes and its complications and comorbidities or with
related metabolic and endocrine disorders. The MDRC Clinical Core provides MDRC clinical investigators:
 Well-equipped and accessible clinical research space, equipment, and support for diabetes-related studies,
 Expertise and resources to facilitate the access to electronic health record (EHR) data and to recruit of
diabetic subjects for diabetes-related clinical studies,
 Expertise and state-of-the-art laboratory analytical services, and
 Biostatistical services to address experimental design, data management, and data analysis.
Since its creation ten years ago, the Clinical Core has adapted to the changing University of Michigan (U-M)
research environment and the evolving needs of MDRC investigators to provide ready access to well-equipped
clinical research space and support, and to expand access to potential research subjects and clinical data
using the EHR. In addition, the Clinical Core has rolled out new laboratory services with excellent quality
control and low cost. It has also brought on new staff to assist with study design, data management, and data
analysis. All of these services are designed to facilitate diabetes-related clinical research and collaboration.
Discoveries made at a molecular or whole animal level can be tested in human subjects using the resources of
the Clinical Core. Similarly, observations made using Clinical Core resources can be understood at a more
detailed and mechanistic level using resources provided by MDRC biomedical research cores.